Sensorimotor mechanisms of vocal hyperfunction

Project Summary
Vocal hyperfunction (VH) is a highly prevalent feature in the 3 – 9% of the U.S. population with voice disorders.
Characterized by excessive and/or incoordinated laryngeal and perilaryngeal tension, its pathophysiology has
been attributed to many potential etiologies, such as poor vocal hygiene, psychological factors, reflux, and
atypical autonomic nervous system (ANS) function. Our central hypothesis, supported by our recent findings, is
that auditory-motor function is impaired in some individuals with VH: we found impairments in speakers' auditory
acuity to differences in recordings of their own voice fundamental frequency (fo) and their adaptive responses to
artificial shifts in their own voice fo. In this cycle we propose to further elucidate the etiologic role of disrupted
auditory-motor function in VH and to evaluate measures of auditory-motor function that have clinical applicability.
In Aim 1, individuals with VH and controls will participate in tasks to derive fo adaptive responses with and without
a simultaneous cognitive stressor to elicit ANS arousal. Converging evidence suggests that atypical ANS function
is a potential etiologic factor in VH, and that the level of ANS arousal may be associated with impairments in
auditory-motor function. Thus, we will directly assess whether disrupted ANS and auditory-motor function
represent a shared endophenotype (related predisposing factors) in the etiology of VH. In Aim 2, fo acuity and
adaptive responses will be investigated longitudinally in VH. Our pilot data indicate that many individuals with
VH and atypical auditory-motor features show improvement in their adaptive responses immediately after voice
therapy. This may represent normalization of an underlying etiologic factor. Conversely, voice therapy may
provide strategies to improve vocal quality, without addressing the underlying neural vulnerability of individuals
to develop VH, with changes in auditory-motor adaptation that are secondary. We anticipate that individuals with
atypical auditory-motor features immediately post-therapy will have poorer long-term responses to therapy, with
the implication that disrupted auditory-motor control is an etiologic factor in the development and persistence of
VH. The fo perturbation methods employed in Aim 1 and Aim 2 require precise calibration of instrumentation and
well-controlled acoustic environments, limiting their clinical viability. Therefore, in Aim 3, potential “clinic-friendly”
correlates (auditory acuity to shifts in the fo of a standard voice and production of speech before, during, and
after being exposed to a noisy environment to induce a Lombard response) will be psychometrically evaluated
in terms of their concurrent validity and test-retest reliability. Successful completion of these Aims will provide
theoretical and clinical insight, contributing directly to all Center Aims: delineation of the etiology and
pathophysiology of VH, more specific phenotyping of VH, and improved methods for prevention, diagnosis, and
treatment of VH. This understanding could allow for assessments that are sensitive to each patient's specific
endophenotype, allowing personalized therapy approaches based on underlying mechanisms.

Public health relevance
Project Narrative Vocal hyperfunction is a condition that accounts for nearly half of the 3 – 9% of the U.S. population with voice disorders. It often presents with no known structural or neurological cause. This project will test the hypothesis that vocal hyperfunction is related to underlying auditory-motor impairment, allowing for future development of new treatments.